Learning and updating internal visual models

? DESCRIPTION (provided by applicant): In line with the strategic plan of the NEI, this project is focused on filling a profound gap in our understanding of neural mechanisms of visual perception. Specifically, we aim to understand how the adaptation of visual cortical circuits contributes to perception. Adaptation is a ubiquitous process by which neural processing and perception are dramatically influenced by recent visual inputs. However, the functional purpose of adaptation is poorly understood. Based on preliminary data, this project tests the hypothesis that visual adaptation instantiates a form of predictive coding, which is used to make unexpected events salient. We posit that cortical circuits learn the statistical structure of visua input in a manner that extends beyond previous fatigue- based descriptions of adaptation effects. This learning is used to discount expected features and signal novel ones. Our project will test this hypothesis through the collaborative effort of three investigators with expertise in human EEG, animal neurophysiology, and computational modeling. Aim 1 will assess the ability of cortical circuits to adapt to temporal sequences of input and to signal deviations from expected sequences. Aim 2 will evaluate the effect of stimulus uncertainty on adaptation and responses to novel events. Aim 3 will determine how adaptation dynamics and responses to novel stimuli are influenced by the temporal constancy of stimulus statistics. Each of these aims involves an experimental manipulation that yields distinct behavior from fatigue- based and predictive coding mechanisms. Thus, together our aims will provide a robust test of our core hypothesis, and provide a much richer understanding of the adaptive properties of cortical circuits. Results from our project will contribute to answering one of the continuing puzzles in visual research, which is to understand the functional purpose of adaptive mechanisms in visual perception.

Public health relevance
PUBLIC HEALTH RELEVANCE: . This research is relevant to public health because it aims to uncover the function of visual adaptation, a fundamental aspect of visual perception. This work is thus essential to the mission of NEI because it will provide a more detailed understanding of how visual cortical circuits underlie visual perception, which is necessary for developing treatment strategies for individuals with visual processing deficits and for the development of effective prosthetic devices.